Curation and Informatics

PROJECT SUMMARY: CURATON AND INFORMATICS COMPONENT
The Squirrel Monkey Breeding and Research Resource (SMBRR), P40 OD010938 is part of the Michale
E Keeling Center for Comparative Medicine and Research (KCCMR) which is a core resource within The
University of Texas MD Anderson Cancer Center. The KCCMR has more than 2,200 nonhuman primates
including the ~ 500 squirrel monkeys that comprise the SMBRR. Health data and monkey demographic
information are routinely collected in the SMBRR individuals as part of their veterinarian care surveillance
program. Additionally, when squirrel monkeys die from natural causes or are euthanized for quality-of-life
reasons, both frozen and formalin-fixed materials are collected from various tissues as well as other
pathological data. Lastly, we have a growing body of genomic data including whole genome sequencing and
DNA methylation data. In the proposed studies, we aim to standardize the curation of health data and
banking of biological materials collected from the SMBRR animals, including genomic data. These data will
be organized across different resource databases to allow for easy access to archived information on all
monkeys. Importantly, in the proposed studies, we will develop a searchable web portal, referred to as the
National Squirrel Monkey Resource (NSMR). Withing the NSMR, users will be able to search and identify
relevant health, biological, genomic or other resource materials available within the SMBRR. Users will also
be able to request specific material through the web portal. To strengthen our ability to quantify use of
materials within the SMBRR, we will also record the number of unique visitors to the NSMR portal, number
of requests for materials and document publications utilizing materials and animals requested via the
NSMR.